Genetic technology development for elucidating lineage plasticity mechanisms in cancer

PROJECT SUMMARY
Lineage identity is an important attribute of human cancer cells, which can influence many aspects of tumor
biology, including metastasis and the response to targeted therapies. In some cancers, such as leukemia and
sarcoma, there exists a powerful block in cell differentiation which can be overcome through pharmacological
modulation of oncoproteins and their epigenetic cofactors. In human carcinomas (e.g. of the pancreas and lung),
tumor cells have a malleable identity and can adopt different cell fates to enhance their fitness in vivo and in
response to therapy. As the Senior Research Investigator of the Vakoc laboratory, I have been responsible for
developing technology for probing lineage identity in cancer using high-throughput genetic screening. This
important research builds upon my deep expertise in cell biology and genetics obtained during my doctoral and
post-doctoral training, with my skillset continuing to expand as I contribute to several ongoing and completed
projects in the Vakoc lab. My technological accomplishments to date include: 1) developing a paralog co-
targeting CRISPR screening methodology, which allows for high-throughput `double knockout' screens in search
of redundant epigenetic and signaling regulators in cancer 2) developing several different marker-based genetic
screening platforms, which we have applied broadly in human cancer models to reveal novel epigenetic
regulators of cell fate and 3) Deep-mutational scanning technology, which allows for saturation mutagenesis of
transcriptional regulators to map all of functional and non-functional mis-sense mutations. As evidenced by our
recent publications, my exploratory screening efforts have yielded compelling and novel modes of epigenetic
and signaling regulation, which I have characterized biochemically and using epigenomics in collaboration with
the students and postdocs in our group. Outlined in this proposal is my plan for the next 5 years that describes
how I will continue to apply advanced genetic screening techniques to address fundamental epigenetic
mechanisms related to our NCI-funded projects focused on pancreatic ductal adenocarcinoma, small cell lung
cancer, and rhabdomyosarcoma. First, I will develop genetic screens for revealing upstream activators of the
MARK kinases, which I recently identified as co-dependencies of YAP/TAZ using paralog co-targeting CRISPR
screens. Second, I will also make effective use of a newly developed deep mutational scanning technique, which
I will apply to two high-value oncology targets KLF5 and POU2F3 in search of functional surfaces of these
transcription factors that engage with their coactivators. Third, I will perform a base editing scan of MED12, in
an effort to pinpoint how this protein supports the function of ∆Np63 in specifying basal identity in pancreatic
cancer. Finally, I will expand our genetic screens in rhabdomyosarcoma to find regulators that sustain the block
in myo-differentiation present in this disease. My technology-driven pursuits are vital to much of the research in
our lab, as it seeks to identify targets for epigenetic therapy in human cancer.

Public health relevance
PROJECT NARRATIVE Lineage plasticity is an emerging hallmark of human cancer, which often reflects the aberrant functioning of the epigenetic machinery that specifies transcription. As a Senior Research Investigator in the Vakoc laboratory, I am the lead technologist that develops and implements novel genetic screening technologies to human carcinoma and sarcoma models, in search of transcriptional mechanisms that control lineage identity as well as targets for epigenetic therapy. In the next five year period, I will advance our NCI-funded research programs by probing epigenetic mechanisms with next-generation genetic screening methods.